Cancer Center Administration

Cancer Center Administration Summary
The Masonic Cancer Center (MCC) Administration enables research excellence by ensuring that the Center
has a strong governance structure that is responsive to organizational and operational challenges, is
strategically aligned and accountable to institutional partners and stakeholders and is informed by data to
ensure strategic prioritization and progress. Under the leadership of Associate Director Aaron Schilz, MPA, the
administration is organized to best align with the organizational structure of the Center. The senior
administrative leadership team includes finance, operations, human resources, research development,
communications, community engagement, translational research administration, development and
advancement coordination, and support activities that align with the mission and vision of MCC. MCC
Administration also supports the program evaluation analysis and reporting to monitor the Center’s progress
towards the goals and objectives of MCC’s Strategic Plan. The Administration includes 178 employees who
provide support for the basic, clinical, and population research and educational missions of the MCC, as well
as for the 245 research members from 49 UMN departments in 11 colleges. MCC collaborates with institutional
partners and stakeholders to showcase the collaborative opportunities and research resources of MCC when
recruiting faculty, resulting in the hiring of 33 new members during the current award period. The MCC FY23
budget was $33M, including a $3.4M (10%) administrative budget.
MCC Administration achieved many impactful accomplishments during the current funding period, including 1)
a 9-month Strategic Plan refresh process that included revising key performance indicators, identifying and
prioritizing projects, and aligning the Center’s governance structure; 2) growth of the Minnesota Cancer Clinical
Trials Network infrastructure (from 1 FTE to a 12-member team) and network size, currently with 3 research
partners (MCC, Mayo Clinic Cancer Center, and The Hormel Institute) and 5 clinical partners (Essentia Health,
Sanford Health, Metro-Minnesota Community Oncology Research Consortium, Mayo Clinic Health System,
and M Health Fairview), each with a varying number of community clinics; 3) renovating 11,000 ft2 of space to
create the Masonic Discovery Lab, which brings together under 1 roof 30+ researchers from across MCC; 4)
building infrastructure of the Community Outreach and Engagement (COE) Office to ensure that COE is
integrated across the Center and that MCC can be effective across the catchment area; 5) establishment of the
MCC Diversity, Equity, and Inclusion Office, setting a path for future support of the Plan to Enhance Diversity;
6) the expansion of operational and evaluation tools to support management of Center-wide metrics, clinical
trial operations, return-on-investment tracking, and Shared Resource management; and 7) the unification of
the Clinical Trial Office into a singular entity that applies expertise across all areas of clinical research.